Optimizing Hematopoietic Stem Cell Transplantation For The Treatment Of Hematological Malignancies

Project Summary/Abstract
Hematopoietic cell transplantation (HCT) is the only curative therapy available for many hematological
malignancies as well as some non-malignant diseases such as hemoglobinopathies, autoimmune diseases, and
inherited metabolic disorders. Key obstacles to the success of HCT include collecting optimal numbers of
hematopoietic stem cells (HSCs) for HCT and/or gene therapy, toxicities due to nontargeted chemotherapy- and
irradiation-based conditioning, control of graft-versus-host disease (GVHD) after allogeneic HCT (allo-HCT) and
treating disease recurrence both before and after HCT. I have focused my career over the last 30 years on
overcoming these obstacles to HCT using a translational research approach. In the last project period, I
designed, led, and/or completed correlative studies for 15 clinical trials, including studies that led to the FDA-
approval of ruxolitinib (JAK1/2 inhibitor) for the treatment of steroid refractory GVHD in 2019 and motixafortide
(CXCR4 inhibitor) plus G-CSF for HSC mobilization for autologous HCT in multiple myeloma (MM) in 2023. I
completed first-in-human clinical trials of the bispecific antibodies Flotetuzumab and AMV564 in patients with
relapsed or refractory (r/r) AML, treated the first patient with multiple myeloma (MM) with our home-grown CS1
chimeric antigen receptor T cell (CART) produced in our new GMP facility, developed an ‘off-the-shelf’ universal
allogeneic CART targeting CD7 (UCART7) that lacks CD7 and TRAC to minimize the risk of fratricide and GVHD,
respectively, and completed a global (12 sites; 7 domestic and 5 international) Phase I trial testing UCART7 in
patients with r/r T-ALL/LBL that led to an upcoming Phase II registration trial. I also discovered a novel
conditioning strategy combining CD45- or cKit-targeted antibody-drug conjugates (ADCs) with JAK1/2 inhibitors
to enable robust donor engraftment in fully major histocompatibility complex (MHC)-mismatched mice. My
research program over the next seven years will continue to use our strengths in preclinical modeling, cancer
genomics, CART immunotherapy and the design and execution of early phase clinical trials to 1) develop novel
very late antigen 4 (VLA-4) inhibitors for HSC mobilization, gene therapy and GVHD prevention, 2) test if
targeting human CD45 or cKit with ADCs or human CD47 and cKit with naked antibodies, inhibitors, or bispecific
molecules in the presence of JAK1/2 inhibitors can serve as effective conditioning regimens in humanized mouse
models and primates, and 3) develop novel CART against T-ALL, AML, and MM. Three obstacles to successful
CART therapy are: 1) limited CART expansion and persistence, 2) CRS/ICANS, and 3) on-target/off-tumor
toxicities. I will test if long-acting cytokines of IL-7, IL-15 and/or IL-21 enhance CART expansion, persistence,
and function. To address toxicity, we will continue testing duvelisib in humans and define the mechanism/s
whereby PI3K-γ,δ inhibitors, JAK1/2 inhibitors and CD40L/CD40 blockade reduces CRS/ICANS without
inhibiting CART. To minimize on-target/off-tumor toxicities, we will engineer epitopes on CART and/or donor
HSCs used in allo-HCT to provide selective resistance to CART without altering the function of the edited protein.

Public health relevance
Project Narrative This proposal is relevant to public health because hematopoietic cell transplantation (HCT) is the only curative therapy available for many hematological malignancies as well as some non-malignant diseases such as hemoglobinopathies, immunodeficiencies, autoimmune diseases, and inherited disorders of metabolism. We will attempt to overcome many of the major limitations to successful HCT by designing and testing in clinical trials our basic science observations which have identified novel methods of 1) mobilizing hematopoietic stem cells into the blood for collection for HCT and gene therapy, 2) conditioning patients to prepare them for HCT, 3) preventing graft-versus-host disease after allogeneic HCT, and 4) treating cancer (AML, T-ALL, multiple myeloma, and/or B cell malignancies) before or after HCT with genetically-modified immune cells named chimeric antigen receptor T cells (CART) that are designed to specifically attack and kill the cancer without hurting the patient. Our proposed clinical and preclinical studies will guide future basic research and clinical trials and potentially provide more patients the opportunity to undergo lifesaving HCT.